O-glycosylation of cysteine-rich modules

The overall goal of our research is to determine the structures, modification sites, biosynthesis, and functions
of sugars (O-glycans) linked to two cysteine-rich domains: Epidermal Growth Factor-like Repeats (EGFs) and
Thrombospondin Type 1 Repeats (TSRs). Both EGFs and TSRs are found in numerous cell-surface and
extracellular proteins. We focus on two modifications on EGFs, O-fucose (added by Protein O-
fucosyltransferase 1, POFUT1) and O-glucose (added by Protein O-glucosyltransferase 1, POGLUT1). We
also study O-fucose (added by POFUT2) on TSRs. All three enzymes modify hydroxyl groups of specific
serines or threonines in well characterized consensus sequences within EGFs or TSRs. Knockouts of these
enzymes are embryonic lethal in mice, and mutations in POFUT1 or POGLUT1 cause human genetic
disorders, demonstrating the biological importance of these modifications. We propose to address several
unanswered questions about the proteins modified by these O-glycans. For instance, we want to determine
the O-fucose proteome. To understand O-fucose function, we need to know which proteins are modified.
While database searches with the consensus sequences for POFUT1 and POFUT2 have successfully
identified many target proteins, recent data has revealed a different cysteine-rich domain modified with O-
fucose, an EMI domain in Multimerin1, which was not identified in our searches. Here we describe an unbiased
approach to identify O-fucosylated proteins using a bioorthogonal probe, 6-alkynyl fucose (6AF), that is
efficiently and preferentially incorporated into O-fucosylated proteins in cells. We expect to confirm a number of
predicted substrates for POFUT1 and POFUT2, which will provide novel targets to study, but also to identify
proteins that did not appear in database searches. We also want to examine the structure and function of
O-fucose and O-glucose modifications on NOTCH3. In the past few years we have mapped O-fucose
glycans to sites on NOTCH1 and NOTCH2 using glycoproteomic methods and determined which sites play
biologically important roles. NOTCH3 is known to play important roles in vascular homeostasis, and mutations
in NOTCH3 cause CADASIL, a devastating, autosomal dominant vascular disorder. The molecular
mechanisms resulting in CADASIL are poorly understood. CADASIL mutations add or remove cysteines in
NOTCH3 EGFs, which are predicted to disrupt glycosylation. We will map glycosylation sites on NOTCH3
isolated from vascular smooth muscle cells and evaluate how CADASIL mutations affect its glycosylation
status. Finally, POFUT1 and POFUT2 are both soluble enzymes located in the lumen of the endoplasmic
reticulum (ER), but their donor substrate, GDP-fucose, is synthesized in the cytosol. It is not known how
GDP-fucose is transported into the ER. Here we describe a CRISPR-Cas9 screen to identify the putative ER
GDP-fucose transporter. These studies will extend our understanding of the structure and function of O-
glycans on cysteine-rich domains and their potential roles in diseases.

Public health relevance
Addition of sugars to proteins (glycosylation) is required for proper development, and defects in glycosylation cause a variety of genetic disorders. Here we propose studies on specific types of glycosylation found on cysteine-rich domains of proteins. We seek to identify proteins with these types of glycosylation, examine how these glycans are affected in a genetic vascular disorder called CADASIL, and learn more about the genes involved in their biosynthesis.